An integrated approach to understanding the molecular mechanisms of cation-coupled transport

Project Summary/Abstract:
Cation-coupled secondary active transporters play critical roles in many aspects of cell physiology,
and pharmacokinetics, and are also involved in many serious diseases. Based upon decades of effort in
structural biology and biochemistry, we now know the architecture, folding, substrate binding, and global
conformational change of many transporters. However, for many transporters, we still have a deeply
incomplete understanding of transport mechanisms. Critically, many important mammalian transporters
remain structurally and functionally uncharacterized. My laboratory has been working on fundamental
questions of cation-coupled sugar symport using a prototype bacterial transporter, the Na+-coupled
melibiose symporter MelB. In the past 5 years, we have achieved important milestones, including the
determination of MelB structures in two distinct kinetic states with bound sugar or Na+ and the
construction of novel mechanisms of symport utilizing structural, functional, biochemical, and biophysical
methods. By further applying and extending these successful methods in the next 5 years, we will expand
our research to include the study of the mammalian Na+-coupled epithelial amino acid co-transporter
SLC6A14, involved in several chronic diseases, including cancer. Significantly, we have made critical
breakthroughs and have succeeded in the expression, purification, and functional reconstitution of
SLC6A14. The use of purified SLC6A14 is a critical complement for validating the published data from
cell-based assays where other amino acid transporters may be present. For cryoEM-single particle
analysis, we will develop suitable fiducial tools to increase structure determination throughput; these tools
will be of great utility to the more general membrane protein structural biology community. Our SLC6A14
structures, combined with results from other approaches we regularly utilize, will provide insight into its
broad substrate specificity and inhibitory mechanisms by its inhibitor, an important input for potential
inhibitor development. For MelB, we will further examine our proposed cooperative binding-based core
symport mechanism by determining missing key structure(s) and analyzing conformational dynamics
using hydrogen/deuterium exchange-mass spectrometry and molecular dynamics simulations. We will
stabilize MelB at specific state(s) using nanobodies or binding proteins obtained from different scaffolds
and will determine their structures by cryoEM. Biochemically, these stabilized states will uniquely enable
a better understanding of relationships between substrate binding and conformational dynamics. The
expected new structures and functional studies of both Na+-coupled nutrient symporters SLC6A14 and
MelB will provide critical novel knowledge about the molecular basis of ion-coupled transport and coupling
mechanisms. This research can significantly impact the development of new therapeutic strategies for a
broad range of chronic diseases including cancer.
1

Public health relevance
Project Narrative Ion-coupled transporters play important roles. We will characterize two Na+-coupled transporters that is involved in health and serves as a prototype for the study of ion-coupled transport mechanisms structurally and functionally. The expected outcome will improve our fundamental knowledge of active transport and impact novel drug development. 1